SCH: Multi-modal Biosensing and Predictive Analytics for Continuous Monitoring of Mobility and Cognition in an Aging Population

PROJECT SUMMARY (See instructions):
Declines in cognitive and motor function are early harbingers of pending Alzheimer's Disease and related
dementia (AD/ADRD). New technologies for characterizing mobility and cognition have made significant
inroads within the younger, healthier population segments but have not permeated all demographics,
especially among older adults. Additionally, current approaches for monitoring cognition and mobility are
limited to periodic assessments in laboratory and clinical settings, which fail to capture the subtle
gradation and continuous deterioration of these domains. To address this gap, we propose a multi-modal
system of wearable sensors that will provide data to enable breakthroughs in statistical machine learning
and health informatics, allowing for a nuanced, continuous assessment of mobility and cognition.
Critically, our combined hardware/software system will address the unique challenges of an aging
population including the need for a health monitoring system which is both comfortable and easy to use.
In Aim 1, we will develop a system of wearable eutectogel sensor patches that are flexible and breathable,
transparent, and inconspicuous. These individual sensor devices, designed for long-term wear, will
provide direct, continuous, real-time monitoring of eight biophysical domains (gait, posture, head motion,
heart rate variability, respiration, location, orientation, and movement). In Aim 2, building on
state-of-the-art methods for the modeling and analysis of multiple time series, we will develop statistical
machine learning algorithms and models for the estimation of cognitive function and mobility over time
given data from the gel-biosensors. To validate the resulting engineered system, we undertake a
feasibility study to determine the potential of the analytics-enhanced, integrated biosensor system and
machine learning algorithms to predict cognitive function and mobility in 20 older men and women,
starting in a controlled laboratory setting and extending into real-world scenarios. We anticipate our
gel-based biosensor system and machine learning models will advance personalized sensing and health
informatics with long term, direct application to detecting and predicting early development and
progression of AD/ADRD that increasing numbers of older adults are now facing.

Public health relevance
RELEVANCE (See instructions): The proposed project will develop and test an easy-to-use multi-modal monitoring system of sensors and data processing algorithms intended for use by older adults to reveal subtle changes in cognition and mobility, both early indicators of pending Alzheimer's disease and related dementia. This will provide important insight into an early window for interventions to delay or prevent the onset of these devastating health outcomes. The results of this project will thus support the National Institute on Aging's Strategic